Role of phospho UBC9 in alcohol-associated liver disease

ABSTRACT
Alcoholic associated liver disease (ALD) is a consequence of chronic alcohol consumption that leads to
hepatocellular injury and liver inflammation. Alcohol abuse increases the translocation of gut-derived endotoxins
(lipopolysaccharide; LPS) to the portal circulation and causes Kupffer cells activation, the resident macrophages
in the liver, through Toll-like receptor 4 (TLR4) signaling, leading to nuclear regulatory factor kappa B (NF-κB)
activation, secretion of inflammatory cytokines, including tumor necrosis factor alpha (TNF-α) and production of
reactive oxygen species (ROS) . SUMOylation is a posttranslational modification that involves addition of SUMOs
(small ubiquitin-like modifiers) modulating protein stability, activity and localization. Several studies have
intimated a close relationship between SUMOylation and ROS. We recently demonstrated that ubiquitin
Conjugating Enzyme 9 (UBC9), the sole E2 protein required by the SUMOylation machinery, is upregulated in
murine NIAAA and Intragastric models. We also found that UBC9 is phosphorylated and this is correlated with
high level of SUMOylation activity in LPS-activated KCs that leads to inflammation. In addition, we elucidated
the key function of SUMOylated microsomal Cytochrome P450 2E1 (CYP2E1) in ALD that sustains its enzymatic
activity and protein stability. However, several important mechanistic pathways that are altered in ALD have not
been investigated yet. By phospho-peptide mapping of LPS-activated KCs and NIAAA KCs, we found that UBC9
was phosphorylated at two serine residues (S2 and S7) and one tyrosine residue (Y68). Interestingly, the S2
and S7 UBC9 phospho-events were found in both normal and activated KCs whereas Y68 phosphorylation was
induced specifically in activated cells. In order to examine whether UBC9 phosphorylation has pro-inflammatory
effects in KCs in ALD, Mass Spectrometry (MS) was performed to identify UBC9 interacting proteins in isolated-
NIAAA KCs. Crosslinking proteomics revealed interaction of UBC9 with several inflammatory pathways.
Furthermore, phospho-UBC9 was found to interact favorably with components of NF-κB signaling. CRISPR-
directed gene editing of the Y68 and S2 residues (but not S7) of UBC9 lowered inflammatory cytokines in
activated KCs. These data provide the rationale to examine how phospho-UBC9 regulates components of
inflammatory signaling. This proposal tests the novel hypothesis that ethanol induces KCs activation in
ALD by modulating UBC9’s biological activity and this may impact key inflammatory response signaling
pathways. Three specific aims are proposed: 1) Examine how phosphorylation of UBC9 influences its
biological function upon alcohol exposure, 2) Investigate the effect of UBC9 Y68 phosphorylation on the
crosstalk between KCs and hepatocytes in ALD, 3) Examine the effects of UBC9 Y68 gene editing on c-
SRC interaction in ALD. If successfully completed, these studies should provide highly novel information on
the role of phosphor UBC9 in the development of ALD and may provide novel therapeutic strategies, which is of
high

Public health relevance
PROJECT NARRATIVE Chronic alcohol consumption leads to hepatocellular injury, fat accumulation, and liver inflammation and sometimes leads to liver cirrhosis or hepatocellular carcinoma. We have found that changes in phosphorylation status of UBC9, an essential enzyme required for SUMOylation (post-translational modification), is associated with altered inflammatory response and liver function. Our proposal aims to investigate how phospho UBC9 modifications in liver macrophages can be controlled and may provide a therapeutic target for alcoholic associated liver disease.